FY21 CONSOLIDATED FACILITIES TASK ORDER D- REFURBISHMENT AND INFRASTRUCTURE PROJECTS FOCUSED ON FACILITY IMPROVEMENTS WITHIN THE NCI AT FREDERICK CAMP

PURPOSE OF THE PROJECT / TASK
1.1 This project is intended to replace the existing backup generator at Building
376 with a new, more reliable unit.
2.0 PROGRAM OF REQUIREMENTS
2.1 General Requirements
2.1.1 Required Site Interfaces. This will be a subcontracted construction
project performed in Building 376.
2.1.2 Parking. There is minimal parking in the area for the craft workers. A
Parking / Laydown Area will be determined and presented to the
Contractor as part of the procurement process.